Meet Me on the Pitch: Developing and testing a community-based sports and behavioral health intervention for newcomer youth

PROJECT SUMMARY
Refugee and immigrant “newcomer” youth who have arrived in the United States in the last five years
frequently have unmet mental health challenges and face significant cultural and structural barriers to
accessing quality health services. Newcomer youth represent racial and ethnic minority populations with
substantial health disparities, overwhelmingly have lower socioeconomic status, and live in lower income
communities. Social determinants of health (SDoH) within these communities drive disparities in behavioral
and mental health for newcomers, which are further exacerbated by other unique barriers such as
discrimination, fear of deportation, and acculturative stress.
The proposed project, “Meet Me on the Pitch (MMotP): Developing and testing a community-based sports and
behavioral health intervention for newcomer youth,” will develop and evaluate an innovative model that
integrates sports, school, and behavioral health to improve the health of newcomer youth. MMotP is a novel
approach that builds on evidence-based practices to promote health equity by using sports as a means of
fostering community and social emotional development. MMotP is co-designed with newcomer youth and their
coaches to address SDoH. By training trusted community members (specifically, soccer coaches) to deliver a
culturally responsive behavioral health intervention, MMotP transforms the traditional service delivery model
and addresses the specific needs of newcomer youth. It focuses on changing key SDoH at the community
level rather than on individual-level treatment and creates an entry point to health care for youth by training
coaches to provide basic support and referrals.
The study proposes a mixed-methods approach that aims to 1) develop and refine the MMotP intervention,
including an enhanced referral network; 2) assess its feasibility and acceptability among newcomer youth; and
3) measure the short-term impact of the intervention among newcomer youth. The study will employ a
transcreational framework for intervention design, engaging the community, program participants, and coaches
to plan, deliver, and evaluate the intervention. Focus groups and key informant interviews will inform
intervention development and refinement, followed by longitudinal surveys to assess program quality and
impact. Through a randomized controlled trial with 480 newcomer youth, the study will assess the short-term
effects of MMotP on mental health outcomes and the related SDoH of access to healthcare services, school
engagement, and social connection. Embedding a behavioral health intervention within community-based
sports programs provides an upstream leverage point for mental health screening and prevention, a pathway
to social and health services, and enhanced school engagement. If successful, this intervention and study
findings have the potential to transform behavioral health service delivery and ultimately improve health equity
for underserved youth nationwide.

Public health relevance
PROJECT NARRATIVE Aiming to address the significant mental health needs and barriers to care faced by refugee and immigrant “newcomer” youth in the United States, this project proposes a community-based intervention, “Meet Me on the Pitch,” that integrates behavioral health services, school, and sports programming. The study will apply a mixed-methods approach to develop and refine the intervention, assess its feasibility and acceptability among newcomer youth, and measure the short-term impact of the intervention on mental health outcomes and related social determinants of health including access to healthcare services, school engagement, and social connection of participants. Through rigorous evaluation and authentic community engagement to develop and implement this intervention, this project offers an innovative, upstream approach to transforming behavioral and mental health service delivery and can inform strategies to improve health equity for underserved youth.